A Strengths-Based, Intersectional Approach to Suicide Prevention Among Black Sexual and Gender Minority Youth

PROJECT SUMMARY
Black sexual and gender minority (SGM) youth demonstrate higher rates of suicidal ideation and behavior than
White SGM youth and Black cisgender heterosexual youth. However, limited research has examined racial,
sexual, and gender identities as they co-occur and intersect to result in experiences producing suicide risk and
protection among Black SGM youth. Further, suicide research often lacks intercategorical comparisons needed
to understand suicide risk and protection across subgroups of Black SGM youth, limited research has
examined Black SGM-specific protective factors as moderators of suicide risk, and most research has relied on
single method inquiries that limit understanding of the constellation of factors associated with suicide risk
among Black SGM youth over time and across a week. We propose to conduct a multi-level, multi-component
mixed-methods, longitudinal study to examine how intersectional minority stress and Black SGM-specific
protective factors affect active suicide ideation over time, day-to-day, and within specific contexts within and
between populations of Black SGM youth. We will pursue the following specific aims: (1) To examine the
moderating effects of intersectional Black SGM-specific individual and community protective factors on
theoretical pathways of risk, including intersectional minority stress, over time; (2) To identify and describe
proximal correlates of suicide risk, including protective factors, among Black SGM youth; and (3) To explore in-
depth the effects of contextual factors on suicide risk among Black SGM youth. We will recruit 625 Black SGM
youth aged 13 to 26 in the U.S. via social media marketing and impose sampling quotas based on SGM
identity (lesbian, gay, bisexual women, bisexual men, transgender/nonbinary) and age (13-17yrs, 18-21yrs, 22-
26yrs). All participants will complete an online survey every 3 months over 18-months. For Aim 1, we will
perform stratified latent trajectory moderated mediation analyses for SGM groups separately to examine
associations between intersectional discrimination across time as a predictor of change in entrapment and
psychopathology, which in turn predicts changes in the trajectory of active suicide ideation across time. We
hypothesize that individual protective factors will moderate the trajectory of discrimination across time, while
community protective factors will moderate trajectories of psychological vulnerabilities. We also will examine
moderating effects of structural factors. For Aim 2, a subsample of 450 participants will complete 1 of 3 daily
diary surveys over the study period to examine cross-level interactions between person-level protective factors
and day-level risk factors predicting suicide ideation across SGM groups at the daily level. Aim 3 involves
conducting individual interviews with a subset of 180 participants across SGM identities and age groups to
glean insights into contextual factors associated with increasing/decreasing suicide risk. This research will help
address social injustices that characterize mental health disparities among Black SGM youth by identifying
modifiable Black SGM-specific protective factors that will inform future tailored strengths-based interventions.

Public health relevance
PROJECT NARRATIVE This multi-level, multi-component longitudinal, mixed-methods study incorporates an intersectional lens in the examination of how intersectional minority stress and Black sexual and gender minority (SGM)-specific protective factors affect active suicide ideation over time, day-to-day, and within specific contexts both within and between populations of Black SGM youth. Participants will include 625 Black SGM youth aged 13 to 26 who will complete an online survey every three months over an 18-month period to examine moderating effects of Black SGM-specific individual and community protective factors on theoretical pathways of suicide risk, including intersectional minority stress, over time, with a subset of 450 completing one of three burst daily diary surveys to identify proximal correlates of suicide risk, including protective factors, and a subset of 180 completing an individual interview to explore in-depth effects of contextual factors on suicide risk among Black SGM youth. This research will help address social injustices that characterize mental health disparities among Black SGM youth by identifying novel, modifiable Black SGM-specific individual and community protective factors, and effects of structural factors on the experience of intersectional minority stress and suicide risk, that will inform the development of a culturally relevant theory of suicide risk and future tailored, strengths-based suicide prevention interventions for this population.